PHASE I CLINICAL AND PHARMACOKINETIC INVESTIGATION OF FAZARABINE

The objectives of this study are: (1) to determine the therapeutic response to ara-AC (fazarabine) in patients with advanced malignancy; (2) to determine the toxicities of the drug including organ specificity, time course, predictability, and reversibility; and (3) to determine the maximum tolerated dose and use the above information to recommend a starting dose for phase II studies.